The role of lysosomal dysfunction in STING-mediated neurodegeneration from trichloroethylene exposure

Project Summary
This NIH F31 application is a request for support for Neda Ilieva, the Principal Investigator, to conduct research
and career development activities that will equip her with the necessary skills to become an independent
researcher. The project aims to investigate the key proteins, pathways, and mechanisms involved in
environmentally-caused neurodegenerative diseases, particularly Parkinson’s disease (PD).
The primary objective of this research proposal is to explore the role of lysosomal dysfunction and
neuroinflammation in dopaminergic degeneration caused by exposure to trichloroethylene (TCE) in the context
of PD. Previous work from the lab of Dr. Briana De Miranda, the PI’s sponsor, has shown that experimental
exposure to TCE induces nigrostriatal dopaminergic neurodegeneration, motor deficits, endolysosomal
dysfunction, neuroinflammation, and alpha-synuclein accumulation. In a feasibility study, we demonstrated that
acute TCE inhalation induces lysosomal acidification deficits in a transgenic “Lysosensor” mouse. Furthermore,
we showed that TCE exposure results in autophagy lysosomal pathway (ALP) deficits in vitro. We also found
that the innate immune response protein, STING, is elevated in the midbrain tissue of animals exposed to TCE
via inhalation. However, it is currently unknown whether these lysosomal deficits and neuroinflammation are in
tandem with observed pathology or causal in nigrostriatal dopaminergic degeneration. This project aims to
increase our understanding of the mechanisms by which lysosomal deficits induced by TCE contribute to
neurodegeneration and neuroinflammation (Aim 1) and whether STING neuroinflammation is the driving factor
for dopaminergic degeneration (Aim 2). The long-term objective of the PI’s research is to identify the role of
environmental exposures in altering molecular pathways related to normal cellular function and to identify
disease-modifying therapeutic strategies to stop the progression of the disease.
The proposed training plan for Neda Ilieva is sponsored by Dr. Briana De Miranda and co-sponsored by Dr.
David Standaert. The main objective of this plan is to equip Neda with the necessary conceptual and technical
skills required to establish a strong foundation for a career in academic research. The plan has been developed
with activities that focus on three crucial areas: 1) Conceptual and technical research, including studies in
neurodegeneration, cognition, and neurotoxicology; 2) Statistical rigor, reproducibility, and transparency,
including training in ethical research practices; and 3) Career development, including mentorship, teaching, and
scientific communication. This proposal aims to uniquely prepare Neda to conduct rigorous hypothesis-driven
research in neurotoxicology and neurodegenerative disease, while also developing the skills necessary to
become a competent scientist, teacher, and mentor in academic science.

Public health relevance
Project Narrative This research project aims to examine the effects of trichloroethylene (TCE) on Parkinson's disease and investigate the contribution of lysosomal dysfunction in neurodegeneration. The study will employ transgenic mouse lines to ascertain whether lysosomal dysfunction plays a key role in driving neurodegeneration in TCE- treated mice and will also explore the role of STING in the selective degeneration of DA neurons resulting from TCE inhalation. The findings of this research could provide mechanistic insights into future treatment strategies for Parkinson's disease related to environmental toxicant exposures.